Cellular Imaging Facility Core

The Cellular Imaging Facility Core (CIFC) supports the mission of the Southwest Environmental Health Sciences
Center (SWEHSC) to facilitate and implement innovative research aimed at understanding the mechanisms
underlying environmental health science (EHS) risks and disease among people living in arid environments
experiencing climate change by aiding and enhancing the research efforts of Center members through advanced
capabilities to visualize, quantitate, and interpret structural and in situ molecular alterations in tissues and cells
following exposure to environmental toxicants. Importantly, the CIFC ensures the accessibility of microscopy and
specialized imaging techniques, particularly for investigators, staff, and students lacking extensive microscopy
experience. To support SWEHSC investigators, the CIFC provides personalized training and technical
assistance in the use of the affiliated facilities and instrumentation at no additional cost to Center members and
their staff. Likewise, the CIFC ensures that Center members and their labs have state-of-the art equipment and
techniques at their disposal, and that the labs are provided with the relevant scientific expertise and training to
obtain and interpret their data. The CIFC is engaged in all aspects of a study and assists users with experimental
design, technical procedures, instrument optimization and troubleshooting, data analysis, and the final
interpretation of results, including assistance in the preparation of portions of manuscripts and/or grant
applications. Finally, the CIFC encompasses a wide range of imaging techniques that are often used in
combination with, or to confirm, results obtained by molecular biology, biochemical, analytical chemistry, or other
techniques. The CIFC is fully integrated with other SWEHSC resources in a multipronged approach that results
in the acquisition of data and information that cannot be gained by other means, and data that are necessary to
fully determine the sites and modes of toxicant action.